Interpretation Bias as a Mechanism of Treatment Response in OCD

Project Summary
Although exposure and response prevention (ERP) is well-established as the first line of treatment for obsessive-
compulsive disorder (OCD), 40-50% of patients who receive this intervention do not recover. Novel
augmentations are needed to more efficiently target the mechanisms that maintain OCD symptoms in this
population. One candidate mechanism is interpretation bias, the misinterpretation of ambiguous stimuli as
threatening, contributing to the development and maintenance of OCD. In the absence of interventions that more
efficiently and effectively target interpretation bias, it will likely remain difficult to increase rates of treatment
response and decrease relapse. The objective of this proposal is to test the feasibility, acceptability, adherence,
target engagement, and clinical outcomes of an intervention targeting interpretation bias, with the ultimate goal
of contributing to the development of novel, scalable, technology-driven augmentations to ERP. Improvements
in interpretation bias have been associated with OC symptom reduction. Therefore, an accessible intervention
which directly targets interpretation bias may be an ideal augmentation to improve clinical outcomes during ERP.
Cognitive Bias Modification for Interpretation Bias (CBM-I), a computerized intervention, has shown reliable
effects for engagement of interpretation. Studies of CBM-I in OCD have been largely conducted in analogue
samples, and studies with clinical samples have been limited. This proposal will address the critical need of
developing interventions to augment ERP by utilizing CBM-I, with primary aims to: 1) test whether CBM-I induces
changes in interpretation bias in OCD and to determine if these changes are associated with clinical outcomes
across multi-modal assessments, and 2) leverage advances in machine learning to develop personalized
predictions of which individuals with OCD are best-suited for CBM-I. We hypothesize that a multivariate model
incorporating pre-treatment clinical, behavioral and demographic characteristics will predict patient-specific
probability of responding to CBM-I. These aims map onto the candidate’s training goals, with critical new training
and mentorship provided in the areas of: 1) effectiveness trials methodology with an experimental therapeutics
approach (Co-Primary Mentor Dr. Courtney Beard; Co-Mentor Dr. Sabine Wilhelm); 2) ecological momentary
assessment (Co-Primary Mentors Dr. Christian Webb and Dr. Beard; Collaborator Dr. Justin Baker); 3) machine
learning techniques (Dr. Webb and Collaborator Dr. Boyu Ren); and 4) career development (Co-Mentor Dr. Kerry
Ressler). This K23 Award will support an innovative program of patient-oriented research and provide the
candidate with the skills necessary to become an independent investigator focused on advancing the
understanding, prediction, and treatment of non-response and relapse, to optimize outcomes of exposure
therapy for refractory patients with OC-related disorders.

Public health relevance
Project Narrative Nearly half of patients do not recover following the first line of treatment for OCD, exposure and response prevention (ERP). This study proposes to test a novel method of augmenting ERP, a computerized, scalable intervention targeting interpretation bias, which is a critical mechanism underlying OCD. The overall goal is to contribute to the development of technology-driven augmentations to ERP to enhance response rates, which may generalize to treatment for other OC-related and anxiety disorders in the future.